Harnessing Antibody Responses to Prevent and Treat Urinary Tract Infections

SUMMARY
Urinary tract infections (UTIs) affect 15 million women in the United States every year and treatment for UTIs is
becoming more difficult due to high rates of antibiotic resistance. Further, UTIs are highly recurrent. Between 20
and 40% of UTI episodes are followed by recurrent UTIs (rUTIs), with some women suffering as many as 6 or
more recurrences per year. Uropathogenic Escherichia coli (UPEC) is the major causative agent of UTIs.
Antibiotic resistance within UPEC isolates is rising, and the emergence of extended-spectrum beta-lactamase
producing and fluoroquinolone resistant strains is a serious public health concern. Type 1 pili, tipped with the
mannose binding FimH adhesin have been shown to be essential for bladder colonization and UTI pathogenesis
in multiple mouse models. FimH mediates binding to mannosylated uroplakins lining the bladder surface to
facilitate colonization and invasion into bladder cells where they rapidly replicate into intracellular bacterial
communities that protect UPEC from immune cells and antibiotics. In addition, FimH facilitates the ability of
UPEC to establish a reservoir in the GIT, from where they can seed UTIs by ascending from the periurethral
area into the bladder. While UPEC are genetically variable, FimH is part of the core E. coli genome, although
rare strains have been found with mutations in the type 1 operon. Immunization against FimH protects against
UPEC UTI in murine and monkey cystitis models and a FimH-based vaccine has been allowed by the FDA for
patients suffering from multi-drug resistant UPEC. In animal models, protection is antibody-mediated, as FimH-
specific IgG antibodies are found in the urine from protected animals and can protect from UTI through passive
transfer. Intriguingly, UPEC abundance in the gut is increased at the time of symptomatic UTI, suggesting that
gut colonization is a key step in the rUTI cycle. Additionally, studies in this proposal show that eliciting a mucosal
antibody response against FimH can reduce UPEC colonization of the gut. In light of these findings, this proposal
addresses the hypothesis that anti-FimH induced antibodies can combat rUTI by two distinct mechanisms: i)
prevention of UPEC binding to the uroepithelium; and ii) interference with UPEC colonization of the GIT, thereby
lowering the likelihood of UPEC introduction into the urinary tract. The aims of this proposal are to: i) determine
how mucosal vaccination against FimCH reduces UPEC gut colonization (Aim 1); ii) exploit vaccine induced B
cell responses to isolate monoclonal antibodies (mAbs) to FimH and determine their epitope specificity (Aim 2);
and iii) use these mAbs in mouse models of GIT colonization and cystitis in order to elucidate mechanisms of
protection (Aim 3). The research plan will unravel the mechanisms by which anti-FimH antibodies may function
to prevent UTIs by directly blocking bladder binding and indirectly by interfering with UPEC GIT colonization.
These results will inform the rational targeting of the uropathogens that affect millions of people with rUTIs. In
addition, our approach enables the rapid generation of anti-UPEC human mAbs that can be used for therapeutics
and diagnostics.

Public health relevance
NARRATIVE Urinary tract infections (UTIs) affect 15 million women in the US every year and are predominantly caused by uropathogenic E. coli (UPEC). The major adhesin of UPEC, FimH, is needed for colonization of the urinary tract and gut and vaccines targeting FimH have been shown to protect from UTIs, although the mechanism(s) of protection is unknown. This proposal will define how antibodies directed against FimH prevent infection and gut colonization with UPEC.